HYPERGLYCEMIA EFFECTS ON SYMPATHETIC ACTIVITY/RENAL FUNCTION RELATIONSHIP

This study will determine if hyperglycemia induced changes in extracellular volume and sympathetic activity are responsible for the link between autonomic neuropathy, nephropathy and hypertension in insulin dependent diabetics.